LIGHT MICROSCOPE ASSESSMENT OF HIGH PRESSURE FREEZER SAMPLES: PRESERVATION

The light microscope will be used to assess the preservation achieved by the high pressure freezer. In addition to assessment of preservation, fluoresence imaging may be improved over the standard chemical and room temperature protocols, specifically cyroskeletal elements.